DOES URINARY EXCRETION OF HYDROXYPROLINE PREDICT PRETERM LABOR

Research Design: Urine which would normally be discarded will be collected at several normally scheduled prenatal visits and frozen then analyzed later by gel electrophoresis and HPLC color reagent chromotography to determine the ratio of creatinine to hydroxyproline. This will be correlated with the onset of each patient's labor to see if the ratio of hydroxyproline to creatinine rises before the onset of labor.